Addressing Low Cardiac Rehabilitation Participation among Patients with Low Socioeconomic Status

PROJECT SUMMARY/ABSTRACT
Lena Mathews, MD, MHS is an Assistant Professor in the Division of Cardiology at Johns Hopkins University.
Dr. Mathews is applying for a Mentored Patient-Oriented Research Career Development Award in order to
obtain the skills, knowledge and research experience to provide the foundation for a career as an independent
investigator using implementation science to address cardiovascular health disparities. Dr. Mathews’s career
development plan includes interdisciplinary mentorship from Drs. Kunihiro Matsushita, Chiadi E. Ndumele, and
Kristin Riekert; didactics and directed learning; and mentored clinical research adapting and implementing a
theory-based multi-component intervention to increase cardiac rehabilitation (CR) use among individuals with
low socioeconomic status. The specific aims of the research agenda are to: 1) Quantitatively evaluate barriers
to CR referral and enrollment in a diverse hospitalized population by SES, accounting for race, gender and
other sociodemographic characteristics; 2) Qualitatively elucidate perceived barriers to CR utilization in a
diverse clinical population with low socioeconomic status; 3) Adapt and test the feasibility and acceptability of a
navigator intervention, delivered by community health workers and refined by engagement of community
stakeholders, to increase CR utilization among individuals with low socioeconomic status. She seeks to build
upon her research fellowship training in epidemiology and biostatistics, and her clinical background as a
Cardiologist and the Director of Cardiac Rehabilitation at Johns Hopkins, by acquiring additional skills and
expertise required to achieve her career goals. This Mentored Patient-Oriented Research Career Development
(K23) Award will provide her with the opportunity to: 1) develop skills in advanced epidemiology and health
utilization research using electronic health records 2) develop expertise in qualitative methods, to inform
intervention design and evaluation 3) develop skills in behavior change theory to develop clinical interventions
that engage patients with low socioeconomic status; 4) acquire skills in implementation science methods
including community based participatory research; 5) engage in additional career development activities to
enable her transition to independence as a clinician-investigator. Developing these skills during the award
period will support Dr. Mathews’ long-term goal of becoming an independent clinical investigator, leading
efforts to improve the delivery of CVD prevention therapies to marginalized populations, with the ultimate goal
of reducing CVD disparities.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the leading cause of morbidity and mortality, especially among individuals with low socioeconomic status, and addressing the lack of access to cardiac rehabilitation among individuals with low socioeconomic status may be an effective strategy for reducing cardiovascular disease disparities among these high risk medically underserved populations. We propose a theory-based intervention, delivered by community health workers, to increase cardiac rehabilitation participation among individuals with low socioeconomic status that addresses the multi-level barriers they face to enrollment. These research efforts will result in a cardiac rehabilitation intervention that will boost enrollment in patients with low socioeconomic status and reduce the cardiovascular disease disparities.